Advancing rare disease discovery through technological and methodological approaches using an intuitive platform, seqr

PROJECT SUMMARY / ABSTRACT
Over half of all rare disease families remain undiagnosed following exome and genome sequencing analysis.
Remarkable developments in genomic technologies, analytical tools, and innovative data sharing are
advancing Mendelian gene discovery. However, the benefits of these novel advances will only become
realized if they are integrated into widely accessible platforms for genomic analysis. The Broad Institute Center
for Mendelian Genomics has supported the deployment and ongoing development of the seqr genomic
analysis platform, which is freely available to the community either on the AnVIL platform or as an open-source
tool that can be installed locally. This proposal seeks to advance the discovery rate for rare disease through
ongoing development of the seqr platform, incorporating and evaluating the impact of three novel advances: 1)
innovative data sharing through variant level matching by connecting seqr to a growing federated platform of
rare disease and population genomic data with associated phenotype; 2) deployment of automated analytical
tools on previously examined and unsolved cases to identify variation that is newly implicated as pathogenic in
genes with known disease associations or in genes that are newly implicated in disease; and 3) incorporation
of novel technologies such as long read DNA and RNA sequencing data that can be easily analyzed in a
genome-wide manner. We will study the impact of these novel advances by analyzing the diagnostic yield of
each approach. As seqr is freely available and open source, our proposal democratizes the process of genetic
discovery, empowering researchers and clinicians to resolve diagnostic variants, and accelerate the rate of
diagnosis for the global population of individuals with rare genetic disease.

Public health relevance
PROJECT NARRATIVE Over half of all rare disease families remain undiagnosed following exome and genome sequencing analysis, defining the need for innovative tools to aid in variant classification and case interpretation, novel analysis approaches, and new sequencing technologies to enable improved analysis in regions of the genome that are difficult to sequence. We will develop our genomic analysis platform, seqr, to meet these needs and study their impact, by analyzing the diagnostic yield of introducing a globally accessible federated platform for variant matching, integrating automated reanalysis capabilities, and evolving the platform for the analysis of long read sequence data. As seqr is freely available and open source, our proposal democratizes the process of genetic discovery, empowering researchers and clinicians to resolve diagnostic variants, and accelerate the rate of diagnosis for the global population of individuals with rare genetic disease.